GRAIN DUST, ENDOTOXIN, AND AIRFLOW OBSTRUCTION

This is a double-blind, cross-over intervention trial to investigate therelationship between inhalation of endotoxin and lower respiratory tract inflammation in healthy adults.